Structure-based identification of pan-arenavirus sites of vulnerability

PROJECT SUMMARY
Arenaviruses are enveloped RNA viruses with remarkably diverse Old World (OW) and New World (NW)
serogroups that cause hemorrhagic fevers, for which there are currently limited treatment options. At present,
ribavirin is the only off-label antiviral medication with efficacy against Lassa virus. The global prevalence,
pandemic potential, probability for zoonotic transfer, and diversity of arenaviruses therefore justifies a sustained
effort to identify and develop therapeutic countermeasures. Accelerated small molecule discovery, in addition to
distinguishing novel inhibitors, may also provide essential mechanistic details of viral pathogenesis, revealing
the molecular determinants of pan-reactivity of a diverse viral family. The arenavirus surface pre-glycoprotein
polyprotein complex (GPC) and RNA polymerase (RNAP) complexes are two critical components of the viral cell
entry and replication cycle. Given the overall similarity in molecular architecture and specific localized sequence
conservation for each of these molecules across the large arenavirus family, they represent attractive targets for
small molecule inhibitor identification. Recent structural information for prototypic OW and NW arenavirus GPCs
and RNAPs has provided a foundation for identifying molecules that target structurally conserved, cross-reactive
regions of these vital viral proteins. The proposed studies aim to fill a critical void in our understanding of pan-
arenavirus sites of vulnerability through machine learning, artificial neural network molecular screening of small
molecules against arenavirus GPCs (Aim 1) and RNAPs (Aim 2). Further characterization by in vitro structural,
biochemical, and viral neutralization analysis of small molecule candidate inhibitors identified by the in silico
screen will allow for inhibitor optimization for future animal challenge studies and combinatorial therapeutic
development. By identifying GPC or polymerase-targeting molecules with broad, pan-arenavirus activity, we will
define molecular specificities and commonalities of disparate arenavirus GPCs and polymerase complexes to
guide immunogen design.

Public health relevance
PROJECT NARRATIVE Arenaviruses are highly diverse pathogens and the causative agents of various hemorrhagic fevers, with the potential for significant public health and national security impact due to geographic prevalence of serogroups and probability of zoonotic spillover. By combining in silico docking, binding studies, competition assays, and in vitro viral neutralization with high-resolution structural biology of two critical arenavirus proteins- the surface GPC and the RNA polymerase complex- we will utilize small molecule compounds to provide extensive and detailed information on molecularly conserved viral sites that represent areas of broad susceptibility across the arenavirus family. Such information will be vital to the success of future vaccine and therapeutic development efforts and readiness for outbreaks and zoonotic spillover events.